Curation and Informatics

ABSTRACT
The mission of the Rat Resource and Research Center (RRRC) is to provide biomedical investigators with the
rat models, embryonic stem cells, related reagents, protocols, information, support and services that will facilitate
their research. The RRRC serves as a unique repository by importing, storing and distributing a large number of
rat strains/stocks. It assures that valuable models are preserved and made available to interested investigators,
allows researchers to satisfy NIH requirements for resource sharing, relieves individual investigators from the
burden of animal distribution and ensures that models are maintained with rigorous genetic quality control and
health monitoring to promote experimental rigor and reproducibility. As the outward facing presence of the RRRC
to the biomedical community, the RRRC website plays a critical role as does the on-line ordering system.
Curation of the data that exists for all RRRC holdings is a major and important task. To facilitate RRRC internal
operations, numerous custom data management systems are in place. The proposed RRRC Curation and
Informatics Section seeks to build a team of qualified individuals who will be dedicated to overseeing and
improving the website, the on-line ordering system, and the internal data management systems as well as
providing high quality data curation. Creation of this new component of the RRRC will expand our abilities to
provide additional information to users, continually upgrade and improve our website and on-line ordering system
and in general, provide an enhanced experience for our users. Importantly, it will allow prioritization of important
tasks such as website upgrades and prompt data curation of incoming strains/stocks and allow the RRRC to
better explore potential collaborations to share and link data with other Resources. Overall, addition of a Curation
and Informatics Section to the RRRC will improve operations and allow the RRRC to be more impactful to the
research community.

Public health relevance
PROJECT NARRATIVE The addition of a Curation and Informatics Section will provide necessary dedicated personnel and infrastructure to maintain and improve the RRRC website, ordering system and internal databases as well as ensure that data associated with the holdings of the RRRC are well curated. This will enhance RRRC operations and improve the experience of RRRC users.